Digital Uroflowmetry for Office and Home

Abstract
Uroflowmetry is the most common urodynamic test performed by urologists to assess the function of the lower
urinary tract. This simple non-invasive study measures urinary flow rates and when summarized graphically
offers insights into various types of lower urinary tract symptoms. Current systems call upon a patient to void
into a commode with a funnel to direct the flow of urine into a vessel placed on a digital scale which in turn
drives its output into a processor. The processor is connected to a printer which produces summary data
such as voided volume, peak flow, average flow, total void time, as well as a graphical representation of the
flow curve anywhere from 20-30 seconds after the void is initiated or completed. The physician or their
assistant will then empty the vessel, and the system can be used again. Traditionally the paper containing the
printed collected data was filed into a paper chart. Today this tracing is taped to a 2nd paper containing the
patient’s name and medical record number, and this is scanned into the electronic record as an image and the
data become non-searchable. Given this labor intensive process which is restricted to the office, conventional
uroflowmetry is ripe for disruptive innovations that will allow for testing in the patient’s home or office with the
data being driven into the electronic medical record (EMR).
We seek to offer a service to address to these logistical problems based on a detector that is paired with
customized software. Our detector fits in any regular toilet (it can be used in an office setting or at home by
males and females). Uroflow data are acquired in real time by a blue tooth or tablet, which sends the data to
the UroGenie cloud based server, and the summary data is delivered into the EMR. This will allow for a
physician to review multiple flows over time to monitor a patient’s progress without having to open up each
individual image. In this proposal we seek to refine our detector, and modify the software to work in the
home market, and test the service in both office and home locations. Once this system is fully operational we
envision this system being used in office and home settings, and playing a role in drug trials for lower urinary
tract symptoms. The instantaneous detection of flow rate also means it has the potential for future
applications in biofeedback training for selected patients with specific lower urinary tract symptoms.

Public health relevance
Lay Summary Uroflowmetry or the measurement of the speed of urine flow rates remains the most common tool by which urologists can assess the health of the lower urinary tract. Current methods of me asurement are time consuming, rely upon paper records, and are limited to the office. We offer a new system that can be used on any regular toilet in the office or home that will transmit the flow data wirelessly into the electronic medical record.